Obscurin-kinase 1/N-cadherin: a new signaling axis in cardiac structure/function

OBSCN encodes a family of giant, cytoskeletal proteins, obscurins, that play key structural and regulatory
roles in striated muscles. Consistent with this, mutations in OBSCN have been associated with different forms
of cardiomyopathies. Obscurin-B (~870 kDa), the largest known obscurin isoform is a modular protein consisting
of immunoglobulin (Ig) and fibronectin-III (Fn-III) domains followed by an array of tandem signaling motifs and
two COOH-terminal Ser/Thr kinase domains, Kin1 and Kin2 that share ~45% homology with Myosin Light Chain
kinases. Although the presence of Kin1 and Kin2 was discovered almost two decades ago, their enzymatic
activity, catalytic substrates and (patho)physiological roles have remained largely elusive. Recently, our group
demonstrated that both Kin1 and Kin2 are enzymatically active. In particular, Kin1 undergoes autophospho-
rylation and phosphorylates the cytoplasmic domain of N-cadherin. N-cadherin is an essential component of the
adherens junctions (AJ) present in the intercalated disc (ICD), the unique microdomain of the sarcolemma that
mediates the mechanical and electrical coupling of neighboring cardiomyocytes. In view of these findings and
given the coincident distribution of obscurin-B containing Kin1 and N-cadherin at the ICD, we hypothesize that
obscurin-Kin1 plays key roles in cardiomyocyte adhesion and/or communication (at least in part) by modulating
the activities of N-cadherin via phosphorylation of its cytoplasmic domain. We will address this hypothesis by
elucidating the molecular mechanisms that regulate Kin1 activation (Aim 1), determine the role of Kin1-mediated
phosphorylation of N-cadherin in cardiac structure/function (Aim 2), and assessing the impact of a missense
mutation in Kin1 linked to the development of dilated cardiomyopathy (DCM) in humans (Aim 3). During the last
decade, mounting evidence has accumulated, highlighting the intimate involvement of obscurins in cardiac
structure/function in health and the pathogenesis of heart disease when mutated or truncated. Moreover, the
pivotal role of N-cadherin in the mechanical and electrical coupling of adjacent cardiomyocytes has been
extensively documented, although the molecular mechanisms that regulate its functional properties have only
been scantily examined. Our proposal is motivated by this view and will provide important information about the
role of the novel obscurin-Kin1/N-cadherin signaling axis at the ICD in health and how it is compromised in
disease. It will therefore address a fundamental biological question that has translational relevance.

Public health relevance
NARRATIVE During the last ten years, it has become apparent that deregulation or disruption of proteins residing at the Intercalated Disk (ICD), the unique membrane microdomain that mediates the mechanical and electrical coupling of cardiomyocytes, leads to cardiac defects and development of severe or lethal cardiomyopathies. The proposed studies will provide important and novel information about the modulation of a major component of the ICD, N-cadherin, via the enzymatic activity of the obscurin Ser/Thr kinase domain 1. Elucidating the molecular mechanisms that underlie cell-cell adhesion and communication in cardiac muscle during normalcy will allow us to understand how these are altered or compromised during congenital heart disease, and thus enable us to develop new, effective, and targeted therapies.